Multiplexed RNAscope imaging of gene expression in targeted cells across the fly brain

Abstract
Neurotransmitter specification is a crucial step in defining neural circuit identity and function because it
helps establish which neurons communicate with each other. Surprisingly, neurotransmitter specification is
neither mutually exclusive nor immutable. That is, some neurons release multiple types of neurotransmitters
with different physiological functions, and the relative abundance of different neurotransmitters can be modified
based on environmental conditions and neuronal firing patterns. These features endow neurons with a type of
functional plasticity that is often overlooked but can have profound effects on neural circuit function and thus on
behavior. Unfortunately the mechanisms responsible for neurotransmitter plasticity are poorly understood. This
gap in knowledge makes it very difficult to determine the contribution of neurotransmitter plasticity to normal
physiology and to psychiatric disorders involving neural circuit dysfunction. To overcome this obstacle using
fruit flies as a model system we have pioneered a combination of (1) ribosome profiling to identify all
neurotransmitter-associated transcripts in small groups of neurons and (2) RNAscope-based quantification of
transcript distribution across those same neurons, which can be simultaneously targeted by reporters and thus
identified by immunohistochemistry. In this proposal we will employ these exquisitely sensitive techniques to
identify the different neurotransmitters that are used by various arousal-regulating neurons in the circadian
clock network and by neurons that control sleep. We will also use RNAscope to measure how neurotransmitter
identity is modified by changes in neuronal activity, such as those expected during the sleep/wake cycle, and
the extent to which this plasticity is cell-autonomously regulated through synaptic transmission. Lastly, we will
use RNAscope to measure the selectivity of commonly used drivers for labeling of neurotransmitter systems.
Our studies will thus introduce a new, powerful combination of techniques for studying the central nervous
system of the fly, and they will define for the first time the full complement of neurotransmitters used by each
cell of a well-studied behavioral circuit. Our studies will also provide a foundation for determining how
neurotransmitter identity can be modulated by physiological and pathophysiological events to alter neural
circuit function and ultimately behavior. In the long-term such mechanisms are expected to contribute to our
understanding of neural circuit dysfunctions underlying neurological disorders.

Public health relevance
Project Narrative The proposed research is relevant to public health because it will help reveal how brain cells communicate with each other, a process whose dysregulation can lead to disease states. Our findings will help identify new contexts for intervening in such disorders, particularly those involving altered sleep/wake cycles, such as in Alzheimer’s disease.